Administrative Core 1

Adminstrative Core 1: Project Summary/Abstract
Within the SPORE framework, the Administrative Core (Core 1) will be responsible for incorporating the
diverse scientific disciplines of the SPORE investigators into a highly integrated, interdisciplinary approach
focused on achieving excellence in translational melanoma research towards a significant impact on the care
of patients battling this disease. The primary goal of this group is to assure the successful continued oversight
and coordination of all projects, cores, and developmental and career enhancement programs through expert
guidance in fiscal management, centralized communication, and general administration for all activities. This
core will be led by three outstanding scientists and well-established mentors who currently hold high-level
administrative, research, and/or clinical appointments at MD Anderson and possess decades of combined
leadership experience: Drs. Patrick Hwu, Elizabeth Grimm, and Jeffrey E. Lee.
Specific responsibilities of the Administrative Core include the following:
· Compliance with all institutional, federal, and NIH/NCI regulations and requirements.
· Communication and consultation with the NCI project officer and other NCI staff, including preparation
of all required reports, publications, and other requested communications.
· Monitoring data quality control and assurance activities in conjunction with the Biostatistics and
Bioinformatics Core (Core 3).
· Optimization of clinical trial efforts, including monitoring and enhancing accrual progress of related
SPORE clinical trials, through the Clinical Trials Management Resource (co-directed by Dr. Hwu and
Lee) housed within this Administrative Core.
· Maintenance of fiscal and budgetary responsibilities, including implementing the SPORE flexibility
option as appropriate through ongoing assessments of program progress and justifications for funding
allocations/reallocations.
· Convening all necessary meetings, including the Executive Committee, Internal and External Advisory
Boards (IAB/EAB), scientific meetings, research meetings, lectures, and symposia, including
scheduling, development and distribution of meeting materials, and recording minutes as appropriate.
· Coordination and funding of Patient Advocate activities.
· Establishment and monitoring of policies for recruitment and retention of women and minorities in this
program.
· Coordination with other SPORE sites to initiate and enhance collaborative research efforts, co-
sponsor a yearly Skin Cancer conference, and pursue opportunities for high potential Developmental
Research Program (DRP) and Career Enhancement Program (CEP) applications from
collaborating investigators.

Public health relevance
Administrative Core 1: Project Narrative The Administrative Core (Core 1) will be responsible for the successful execution and management of all SPORE activities related to financial oversight and coordination, organization of all necessary meetings, and publicity and record keeping for all projects and the two other cores. This group will also provide regulatory oversight activities for clinical trials; ensure compliance with all institutional, federal, and NCI-specific regulations; and oversee the peer-review and oversight processes of the Career Enhancement Program and Developmental Research Program. The core will be led by Drs. Patrick Hwu, Elizabeth Grimm, and Jeffrey Lee.